SARS-CoV-2 Serological Antibody Testing for Disease Surveillance and Clinical Use

We propose a two-year collaborative project to synchronize data harmonization efforts and analyses of individual-level data in immunocompromised populations to assess effectiveness of vaccine boosters and immune responses using data from 11 Serological Sciences Network (SeroNet) institutions. Our goal is to inform public health guidelines on COVID-19 vaccine and boosters to reduce SARS-CoV-2 infection and severe illness in these vulnerable populations.

Public health relevance
Project Narrative Serologic testing for presence of SARS-CoV-2 antibodies is a critical tool for understanding the epidemiology and designing control strategies for the COVID-19 pandemic. Within a large, integrated health system with rich demographic, behavioral and clinical data, we will develop and implement a large- scale, population-based, flexible platform to assess SARS-CoV-2 sero-prevalence, sero-incidence, risk of sero-conversion and longevity of antibody response. This study will be critical in enhancing our understanding of how to use commercially available, large-scale SARS-CoV-2 antibody testing for population-level and individual-level disease control.